Immunosurveillance of breast glands with oncogenic germline mutations

Project Summary/Abstract
The overarching goal of the proposed research is to realize the immune system's potential for breast cancer
prevention in BRCA mutation carriers. Immunotherapeutic agents have proven effective in treating metastatic
cancers by reinvigorating the antitumor immune responses that develop during cancer progression and
metastasis. In contrast, our research focuses on cancer immunoprevention and aims to identify the immune
pathways that can prevent breast cancer formation in normal breast glands and block pre-cancerous lesions
from advancing to invasive disease in BRCA mutation carriers. This approach raises a unique opportunity to
discover novel immune mechanisms that can be leveraged for breast cancer prevention and therapy in this high-
risk population. With the ultimate goal of early interception that will eliminate the risk of metastatic disease, we
will investigate the underlying mechanisms of immune cell activation that we have discovered in the BRCA
mutant breast glands. We will (1) determine the breast gland-derived immune factors that induce the immune
response in BRCA mutant breast glands, (2) examine the characteristics of the immune cells infiltrating BRCA
mutation breast glands, (3) investigate the impact of the immune cells in BRCA mutant breast glands on cancer
development, and (4) identify novel interventions that can potentiate antitumor functionality of immune cells in
BRCA mutant breast glands. Importantly, we will leverage our optimized animal models to elucidate critical
immune pathways regulating BRCA mutant breast glands that are difficult to discern in human tissues due to
inter-patient heterogeneity. Ultimately, the proposed research aims to establish the foundation for breast cancer
immunoprevention, benefiting patients at high risk of breast cancer development and recurrence.

Public health relevance
Project Narrative This research focuses on an innovative concept that immune cells can be leveraged for breast cancer immunoprevention in BRCA mutation careers. This proposal aims to determine the underlying mechanism that regulates the recruitment of immune cells into BRCA mutant breast glands and devise novel strategies to harness these immune cells to achieve effective cancer prevention in high-risk patients. The outcomes of this research will lead to the development of novel therapies for preventing and treating breast cancer using patients’ immune system.